2015 International Metabolomics Society Conference

? DESCRIPTION (provided by applicant): We propose aiding Early Career Scientists involved in the comprehensive analysis of metabolism (metabolomics) to attend next year's International Metabolomics Society Conference in San Francisco, June 29-July 02, 2015. Scientists will join with a biomedical or clinical focus, including researchers involved in developing and validating methods for improved metabolome coverage, data accuracy, genomics integration and biological context research. The conference organizers will help the Early Career Scientists' committee to arrange topical workshops, present studies and record these sessions for further educational and training use. Comprehensive analysis of metabolism is the corner stone for understanding diabetes and the metabolic syndrome, cancer metabolism and its regulation and dependency on nutrition, and the implications of metabolism in cohort studies and in lung diseases such as asthma. Sessions will focus on the impact of the microbiome on human metabolism and health, genetic variance and its implications on metabolism, different aspects of cardiovascular risk and the metabolic syndrome, integration of multi- omics data into a systems understanding of metabolic regulation, and the impact of human exposures (including food and nutrition) on metabolic health and cancer metabolism as well as drug response metabolism.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will enable Early Career Scientists to attend the 2015 International Metabolomics Society Conference in San Francisco. Early Career Scientists will organize dedicated workshops and scientific sessions and record these as online resource for educational and training purposes.